FIBER OPTIC CATHETER FOR A LASER DOPPLER VELOCITY METER

The objective of the proposed work is to develop a fiber optic catheter that will permit the use of a laser Doppler velocity meter to make in-vivo measurements of velocities in a variety of biological flows. The high spatial and temporal resolution of the laser Doppler velocity meter along with the small size of the fiber optic catheter will allow detailed measurements of fluid velocities not previously possible and will provide key information on a number of important health related problems such as the relation between local fluid dynamics and vascular disease and the influence of airway turbulence on particulate transport and deposition, breath sounds and gas transport during high frequency ventilation. There are three specific aims of this work: 1) to investigate the transmission and scattering properties of blood for the wavelengths of laser light to be used; 2) to design and build the optical fiber catheter to transmit and receive the laser light; and 3) to evaluate the system by measuring blood velocities under known flow conditions. The primary difficulty involves the transmission of light through blood so that light scattered from red blood cells approximately 2 mm from the tip of the fiber optic catheter can be detected and analyzed to obtain a velocity signal. Spectrophotometry will be used to measure the transmission characteristics of light through blood as a function of wavelength in order to determine the wavelength of laser to be used. Preliminary investigations indicate a laser in the infra red region would be optimal. The laser will then be coupled to an optical fiber to test the transmission and scattering of light in blood as a function of the relative position of the transmitting and receiving fibers. A high sensitivity avalanche photo diode will be used to detect the received light. The output of the photo diode can then be used by a standard laser Doppler velocity meter signal processing unit to compute the measured velocity. These results will be used to design the optical fiber holder to be tested in a flow loop under steady, laminar flow conditions in order to compare measured and expected values of blood velocities.